Neuromechanical Bases for the Increased Energy Cost of Walking in Aging

PROJECT SUMMARY
Age-related mobility loss is a major public health concern due to its profound negative effect on health and
quality of life. An increased energetic cost to perform activities such as walking has been well-documented in
older adults and may be a primary contributor to age-related mobility loss. However, the mechanisms that
lead to increased energy cost of walking (CoW) remain unclear. The overall aim of this proposal is to
determine how age-related changes in gait strategy combine with contractile and bioenergetic deficits in 3
major locomotory muscle groups to increase CoW. Our working hypothesis is that proximal extensor muscle
weakness in older adults requires relatively greater muscle activation and thus greater use of these muscles to
produce the joint moments needed for walking. This greater “neuromechanical demand” would increase
muscle energy needs, translating to a greater CoW. Robust evidence indicates older muscles are generally
smaller and thus weaker than young muscles, but there is also evidence that declines in muscle strength may
exceed the loss of muscle size in old age. We will address missing knowledge on relative changes in specific
torque (strength/size) of 3 locomotory muscle groups, the consequences on neuromechanical demand and
CoW, and the potential effects of biological sex on these outcomes (Aim 1). The gait strategy used by older
adults may exacerbate the problem of greater CoW. However, comprehensive studies are lacking about the
impact of joint work distribution (e.g., gait strategy) on the neuromechanical demands of proximal muscles,
which may experience a larger decrease in specific torque, and the subsequent consequences for CoW (Aim 2).
Finally, exacerbation of greater CoW in old may occur due to an intrinsic muscle bioenergetic deficit,
quantified as muscle metabolic economy (energy used for a given contraction relative to muscle size). We
expect lower metabolic economy in older than younger muscle, and consequently even greater CoW (Aim 3).
Data will be collected for 30 young (25-40 y) and 60 older (65-85 y) community-dwelling adults. Groups will be
balanced by sex to assess sex as a biological variable and habitual physical activity will be quantified using
accelerometry. We will address these mechanistic hypotheses by measuring: neural (electromyography) and
mechanical (gait analysis, dynamometry) demand during gait, muscle specific torque (dynamometry, magnetic
resonance imaging), and metabolic economy (magnetic resonance spectroscopy, dynamometry) in all 3 major
locomotory muscle groups (hip extensor, knee extensor, plantar flexor). We will also quantify the distributions
of joint work in walking (gait analysis) and energy CoW (indirect calorimetry). The planned approach builds on
our preliminary data, is novel in its assessment of both bioenergetics and biomechanics, and tightly integrates
rigorous biomechanical and physiological methods to arrive at a mechanistic understanding of greater CoW in
aging. The problem addressed- the role of gait mechanics in the increased CoW in older adults- tackles stated
goals of the NIA, as described in this RFA.

Public health relevance
PROJECT NARRATIVE As highlighted by this Request for Applications (RFA-AG-25-030), the increased energy cost of walking in older adults is both a significant threat to mobility and independence in our aging population, and inadequately understood. We propose to clarify this problem and identify potential solutions by applying a unique, interdisciplinary approach to understanding the interacting biomechanical, neuromuscular, energetic, and sex-based factors that may combine to elevate the cost of walking in older adults. Successful completion of this project will provide essential new information about the multiple key factors that influence the cost of walking in humans, and how these interrelated factors are altered in old age.